Physician Migration and its Implications for Puerto Rico's health care system

Project Summary/Abstract
Puerto Rico (PR) is facing a major existential crisis fostered by a 70 billion dollar external debt and recent
natural disasters that have fostered the deterioration of the health infrastructure.1,2,3,4 These events fuelled the
mass migration of physicians to the US mainland, and it is estimated that PR will lose half of its already
depleted physician workforce in the next decade.20 We propose to explore, from a multi-level perspective, how
the PR health care system responds to this physician migration crisis using a conceptual model informed by
theories of migration, spatial stigma, and health care system resilience. We propose the following aims:
Aim 1: Document the role of push and pull factors, as well as the potential role of spatial stigma, on
fostering and/or mitigating physician migration from PR to the mainland US by richly describing the
characteristics of their current and previous work contexts and settings.
Aim 2: Document the geographical migratory patterns of physicians who have moved from PR to the US
mainland in the last decade (2009-2019) as a consequence of the territory's ongoing economic crisis and the
recent natural disaster.
Aim 3: Determine the impact of physician migration on PR's health care system functioning and resilience
through systematic ethnographic observations of sites affected by physician migration.
Aim 4: Develop science-based policy recommendations for the local/federal governments to mitigate
physician migration in PR using findings from Aims 1-3 and input form stakeholders in the health care system.
We will implement a multi-stage mixed methods design. During Stage 1, we will recruit a random
sample of physicians (total N=560) equally divided between migrants and non-migrants. They will complete: a)
in-depth qualitative interviews (n=50) to gather rich descriptions of the factors behind the decision to leave or
stay, b) cognitive interviews for survey refinement (n=10), and c) a brief survey (n=500) to gather information
about the push/pull factors that foster/mitigate migration and the geographical migration patterns of those who
have left (Aims 1 & 2). The survey will allow us to analyze the geographical impact of this phenomenon using
Arc-GIS technology. During Stage 2, we will carry out institutional ethnographic observation/mapping in
settings impacted by physician migration in PR (Aim 3). We will carry out semi-structured qualitative interviews
with a theoretically-driven sample (total N=100) of: health facility administrators (n=20), health policy makers
(n=20), health care professionals (n=30), and patients (n=30) to understand the impact of physician migration
on the health care system's resilience and patient's access to care. In Stage 3, we will develop policy
recommendations to mitigate physician migration, conduct participatory ethnographic workshops with key
stakeholders in the health care system, and implement a targeted dissemination plan. Results will allow us to
assist the local/federal governments in developing strategies to address physician migration.

Public health relevance
Project Narrative Puerto Rico is facing a major existential crisis as it is burdened with a 70 billion dollar external debt and the consequences of a category 5 hurricane. In this economic and natural catastrophe the mass migration of physicians to the US mainland and its implications for the health care system has not been addressed. The proposed project aims to understand the factors associated with this migration and its geographical patterns, as well as its impact on Puerto Rico's health care system.